Hypothalamic Activity and Collective Mouse Behavior in Lab Cages vs Outdoor Colonies

Project Summary
Some of the most interesting and important aspects of behavior and brain function arise from social interactions.
The dynamics of dyads or larger groups of animals can be critical for survival, such as development of territories
and foraging patterns, building of housing structures such as nests or burrows, and co-parenting to ensure that
at least one experienced caretaker is attending to the needs of offspring. Methodological advances in the last
five years now enable studies of the neural circuits for social and parental behavior in complex environments in
ways not formerly feasible or even possible. Specifically, technical developments in wireless recording,
optogenetics for measuring and manipulating certain cell types, algorithms for neural data analysis, methods for
quantifying multi-animal behavioral interactions, and the capacity to store and share large data sets have each
enabled fundamental discoveries and conceptual breakthroughs relating brain activity to quantitative behavior.
In this proposal, we take advantage of each of these advances with an integrated approach to examine
social and parental behavior in mice in the lab as well as outdoors. This application is a collaborative effort
between the Graham lab at Princeton and the Froemke lab at NYU. For the last several years we have been
collaborating, ‘rewilding’ lab mice by placing them outdoors for several weeks at the Stony Ford field station near
the Princeton campus. Rewilded mice express many interesting behaviors that we have developed approaches
for monitoring and tracking, with multimodal imaging and analysis of behavioral and physiological variables. We
believe it is now the time to study these interesting behaviors and interactions, in complex social and spatial
environments in conjunction with neural recordings. The central hypothesis is that neurons of the central oxytocin
system track the identity and behavior of other animals in a social network, promoting pro-social behaviors to
minimize environmental stressors (hunger, hypo- or hyperthermia, crying infants). We will use quantitative
behavioral methods based on RFID tracking, video and thermal imaging, combined with neural recordings from
hypothalamic neurons including oxytocin neurons. In Aim 1 we examine adult social interactions in same-sex
groups of females or males, and in Aim 2 we examine collective parenting by groups of females. Our overall goal
is to determine what features of group dynamics emerge in a complex outdoor ecosystem, and how the oxytocin
system might enable successful navigation of this socio-spatial environment. These studies will provide direct
data towards the central aims of the BRAIN Initiative: quantitative behavioral analysis of interesting multi-animal
behaviors in complex environments coupled to neural data collection, to understand essential brain functions
related to group survival.

Public health relevance
Project Narrative Communal living and cooperative behavior can help ensure group success, the health and well-being of adults and children, and survival of the species. Perhaps the single most important brain system for pro-social behavior and parenting is the hypothalamic oxytocin neuron population, but little is known about how oxytocin neurons respond during group interactions, including in complex outdoor environments. The experiments to be performed in this proposal provide essential data on neural activity during collective behavior of groups of mice first studied in the lab and then examined in the outdoor Stony Ford field station, including a focus on oxytocin for social hierarchy formation, foraging, burrow building, and co-parenting.